Mechanisms of chaperone-mediated folding of beta-propeller proteins essential for vision.

PROJECT SUMMARY
The cytosolic chaperonin CCT is a large protein complex that plays an indispensable role in maintaining
the cellular proteome by assisting in the folding of numerous proteins with complex tertiary structures and
unfavorable folding trajectories. Proper CCT function is vital to human vision as evidenced by the fact that
inactivating mutations in CCT cause Leber Congenital Amaurosis (LCA). CCT contributes to the visual process
by folding the cytoskeletal proteins actin and tubulin as well as other proteins with b-propeller folds that have
essential functions in vison. These include the G protein b1 (Gb1) subunit of the visual G protein transducin, the
G protein b5 (Gb5) subunit of the regulator of G protein signaling 9 (RGS9) dimer, and the BBS2 and BBS7
subunits of the Bardet-Biedl syndrome (BBS) ciliary transport complex, the BBSome. Despite the importance of
CCT in maintaining the proteome, we know very little at the molecular level about how CCT assists in the
folding of these b-propeller proteins and how mutations disrupt folding and cause disease. To address this gap
in knowledge, we propose to determine the structures of human Gb1 and Gb5 and their disease-causing
mutants. Structures of Gb5 bound to CCT and its co-chaperone PhLP1 show progressive step-by-step
formation of the Gb5 b-propeller that reveals its folding trajectory. Unraveling how CCT influences the folding
trajectory of a b-propeller protein represents a breakthrough in understanding chaperone-mediated protein
folding. Moreover, applying these same techniques to misfolding and disease-causing mutants of Gb1 and Gb5
will show how the mutations disrupt their folding trajectories. Finally, we propose to employ our biochemical
and high resolution cryo-EM expertise to understanding biogenesis of the BBSome complex. A key step in
BBSome assembly is the formation of the BBS2-BBS7 dimer, which requires both CCT and three chaperonin-
like (CL-BBS) proteins BBS6, BBS10 and BBS12 to come together. Despite the 18 years since CL-BBS protein
discovery and the predominant role their mutations play in causing BBS, the molecular mechanism by which
the CL-BBS proteins and CCT assist in BBS2 and BBS7 folding and BBS2-BBS7 dimer formation is unknown.
The proposed studies will fill this gap in knowledge and will deepen understanding of the molecular defects
caused by mutations in Gb subunits, BBS7 and CL-BBS proteins. The structural work will establish a
foundation for targeted, structure-based drug design to create new therapies for the retinopathies,
neuropathies and ciliopathies caused by these mutations.

Public health relevance
PROJECT NARRATIVE The cytosolic chaperonin CCT and its co-chaperone phosducin-like protein (PhLP1) perform essential functions in cell signaling by assisting in the folding and assembly of protein complexes that play vital roles in vision and other signaling processes. Using state-of-the-art cryo-EM structural techniques, we propose to determine the folding trajectories of wild-type and disease-causing mutants of G protein b subunits and Bardet- Biedl Syndrome proteins that are mediated by CCT. Exposing the molecular defects in folding caused by these mutations will allow for targeted, structure-based drug design to treat retinal and neurological diseases.